Modeling Causal Effects of Components of Bundled Interventions with Application to a Multilevel Dental Caries Clinical Trial

This proposal seeks to develop new statistical methods applicable to studies of bundled interventions.
Randomized clinical trials, including in dental research, often focus on multi-component and other complex
interventions. Using such ‘bundled’ interventions is appealing as a way to increase power – as well as
simplicity - of the study. An apparent disadvantage is that it is not clear how to assess the effects of individual
components of bundled interventions, which of also of frequent interest. While the measurement of treatment
compliance, and use of causal mediation analysis is commonly recognized as a possible approach, rigorous
methods to identify and estimate causal effects of components are not available. The present research seeks
to fill this important gap. We will first elucidate the assumptions under which causal mediation/path analysis
can be used to determine causal effects of individual intervention components. We propose, as a novel and
relevant estimand, what we refer to as a cluster-specific interventional effect. We will develop an extended
mediation formula/simulation approach to estimating these causal effects. In our second aim, we will extend
methods to handle repeatedly measured mediators and outcomes. As a novel aspect of this aim, new
methods will be developed to analyze summary (or cumulative) measures in a way that respects the causal
order of model variables. We will perform simulation studies to evaluate the properties of the new methods,
and compare them to possible alternative approaches. In addition, we will develop sensitivity analysis
methods to examine the impact of violations of model assumptions, including extended sequential ignorability
as well as structural (e.g., no direct effect) assumptions. In particular, we extend a copula model approach,
previously developed for the single mediator case, to perform sensitivity analyses in the context of more
complex path models. We will develop an R package to allow user-friendly implementation of the new
methods. The new methods will be applied to data from a recently completed cluster-randomized clinical trial
of a multi-component intervention (including multiple provider-level components) to improve dental care
utilization among 3 to 6 year old Medicaid-enrolled children attending well-child visits in primary care settings.
Our analysis will assess the causal effects of individual components of this bundled intervention.

Public health relevance
This project will develop new statistical methods for evaluating the causal effects of bundled (multi- component) treatment. The methods will help in understanding the mechanisms by which complex interventions affect dental outcomes, including behaviors such as taking children to the dentist. The methods may also help in formulating new treatments and predicting their effects. The statistical methods will be applied to real data from a recently completed randomized clinical trial of a multi- component intervention to improve dental care usage and dental caries outcomes. This research will thus yield new statistical methods and knowledge that may lead to improved study designs and predictions of new treatment effects, and ultimately, better health care and dental outcomes.